Harnessing Exercise to Enhance Immunity and Boost Immunotherapy Outcomes in Patients with Lung Cancer

PROJECT SUMMARY
Overview: 1.8 million people die of lung cancer each year across the globe. Immunotherapy, particularly using
immune checkpoint inhibitors (ICIs), has revolutionized lung cancer treatments over the last years projecting a
significant improvement in cancer prognosis; however, response rates of ICIs are only 15-25%, which is in part
due to the lower levels of functional immune cells and insufficient infiltration of immune cells into the tumor.
Furthermore, about 70% of patients with NSCLC receiving ICIs experience immunotherapy-related adverse
events (irAEs) (e.g., metabolic dysregulation, myalgia, and cardiopulmonary disease). An effective intervention
that can enhance treatment responses as well as ameliorate irAEs would be a significant advance in clinical care
for patients with NSCLC on ICIs. Exercise has been emerging as a novel approach that can enhance response
to immunotherapy and reduce irAEs. Exercise can increase the infiltration of neutrophils in the target cells and
circulating levels of T cells and NK cells as well as induce tumor angiogenesis in preclinical settings, which has
the potential to induce a better response to ICIs and cancer suppression. Furthermore, exercise is proven to be
feasible in patients with lung cancer and to increase cardiopulmonary/muscular fitness and metabolic regulation,
which also suggests the potential benefits of exercise to reduce irAEs. However, no exercise clinical studies, to
date, have been conducted in patients with lung cancer receiving ICIs. Also, it is unclear which exercise
prescription, particularly regarding exercise intensity, would yield better immunological and treatment-related
outcomes. Therefore, I propose multi-level clinical research where a pilot randomized clinical trial (K99) will
explore the preliminary efficacy and mechanisms of different exercise training on immune function, which will
inform a larger Phase II trial (R00) to examine the effects of exercise on immunotherapy response rate and irAEs.
Research Plan: The K99 study is a three-arm pilot randomized clinical trial that will compare high-intensity
interval training (HIIT) vs. moderate-intensity continuous training (MICT) vs. usual care (UC) to explore the
preliminary efficacy of exercise on immune function (Aim 1) and provide a proof-of-concept of the mechanisms
by analyzing biomarkers of immune function, exercise-induced cytokines, and cancer progression (Aim 2). These
findings will inform the R00 study, which is a two-arm phase II randomized clinical trial to examine the effects of
exercise (most efficacious training from K99) on immune function (Aim 3a), tumor biomarkers (Aim 3b), and
immunotherapy response and irAEs (Aim 3c).
Career Development Plan: The proposed comprehensive and transdisciplinary training, involving coursework,
mentorship, research involvement, and seminars/meetings, will enable me to (1) obtain the fundamental
expertise necessary to comprehend the roles of exercise in lung cancer immunotherapy and (2) become an
independent researcher who will lead a research group to pioneer the field of ‘Exercise Immuno-Oncology’.

Public health relevance
PROJECT NARRATIVE Only 15-25% patients with lung cancer respond to immunotherapy while more than two thirds of patients experience its side effects. Exercise training yields various physiological changes that can help improve immune function and has the great potential to improve immunotherapy outcomes and reduce its side effects. This multi- level clinical research will explore the mechanisms and efficacy of exercise on immune function and treatment- related outcomes and side effects in patients with lung cancer receiving immunotherapy, which will provide insights of the roles of exercise in immuno-oncology settings and ultimately to improve long-term cancer survivorship in this patient population who are vulnerable yet understudied.